Core C: Research Experience and Training Coordination Core (RETCC)

RETCC Summary
Trainees engaged in SRP-related research through the Baylor College of Medicine (BCM)-Rice SRP will be
afforded all of the opportunities and benefits through our Research Experience and Training Coordination Core
(RETCC). Our RETCC will continue to harness the resources of BCM and Rice University, both outstanding
research institutions that have a solid history of training successful scientists and engineers. These institutions
have a long history of academic cooperation, along with the other Texas Medical Center institutions, including
the University of Texas Medical Branch at Galveston (UTMB) and M.D. Anderson Cancer Center (MDACC). Our
trainees will also benefit from our newly established collaboration through Baylor University (BU). By partnering
with BU, our trainees will have the opportunity for real-world environmental sampling with Dr. Cole Matson, a
Research Translation Coordinator. Our newly established Research Support Core, the Analytical and
Environmental Chemistry Core (AECC) through BU will also offer training in environmental chemistry data
analysis and interpretation. Members of our Data Management and Analysis Core (DMAC) are committed to
providing trainees the opportunity to learn multi’omics data analysis and machine learning approaches to data
integration. The BCM-Rice SRP is poised to continue our highly innovative training program within the largest
medical center in the world focused specifically on scientific and medical research related to environmental
impacts of Superfund site contaminants of concern. The purpose of the RETCC core is to create a cross-
disciplinary training environment and mentorship program to help develop next-generation scientists and
engineers to tackle complex environmental health and biomedical science challenges relevant to Superfund-
oriented research. This RETCC will leverage the numerous resources in the Texas Medical Center relating to
environmental health and science. Dr. Dan Gorelick has been recruited as an RETCC co-Leader. He is currently
a co-Director for the established T32 Training in Precision Environmental Health Sciences (TPEHS) program, a
joint initiative between BCM and University of Texas Health Science Center – Houston School of Public Health
and MDACC. Trainees will benefit from courses and seminars initiated by the Gulf Coast Center for Precision
Environmental Health, an NIEHS-funded Center directed by Dr. Cheryl Walker. Our SRP focuses on detecting
and assessing the effect of maternal polycyclic aromatic hydrocarbon exposures on fetal and childhood health
and health impacts of potential remediation strategies. The established research projects encompassed in our
SRP will expose trainees to innovative approaches, state-of-the-art technologies, and established
investigators/mentors to accomplish hypothesis-driven research and importantly, use their findings to bring about
lasting change to communities and Superfund stakeholders.

Public health relevance
RETCC Narrative The BCM-Rice SRP is poised to continue our highly innovative training program within the largest medical center in the world focused specifically on scientific and medical research related to environmental impacts of Superfund site contaminants of concern and leveraging the resources of BCM, Rice University, UTMB and Baylor University, all outstanding research institutions that have a solid history of training successful scientists and engineers. Our trainees will have the opportunity for real-world environmental sampling, training in environmental chemistry data analysis and interpretation, as well as multi’omics data analysis and machine learning approaches to data integration. Our RETCC leadership, with collective decades of experience mentoring and administrating training grants, will leverage the numerous resources in the Texas Medical Center relating to environmental health and science including the Precision Environmental Health Sciences (TPEHS) program and the Gulf Coast Center for Precision Environmental Health, ensuring a myriad of opportunities for professional development for our trainees.